2016 Metallocofactors Gordon Research Conference

? DESCRIPTION (provided by applicant): This proposal requests partial support for a new Gordon Research Conference on Metallocofactors as part of the Gordon Research Conference series to be held in Stonehill College (Easton, MA) on June 12-17, 2016 with a broad and long-term goal of bringing together the world's leading experts in metallocofactor biology and chemistry, focusing on enzymatic mechanisms, model complexes, biogenesis, and roles in regulation and human disease in a uniquely cross disciplinary manner. Metallocofactors play essential roles in biology. Understanding these roles and how to exploit them in the context of human health fits well within the NIGMS mission. In nutrition, the importance of essential trace elements reflects their functions as cofactors. In humans these include iron, magnesium, manganese, cobalt, copper, zinc, and molybdenum. Iron-sulfur (FeS) clusters for instance serve as prosthetic groups that confer unique chemical capabilities upon proteins. FeS proteins are also represented in the most central metabolic pathways, including the citric acid cycle and the mitochondrial respiratory chain, the latter of which depends on twelve FeS clusters for function. FeS enzymes play critical roles in the generation of radicals, as demonstrated by the very diverse family of SAM-dependent enzymes. Structurally interesting metallocofactors featuring Fe, Mn, Mo, Ni, and Cu are present in many bacteria and mediate remarkable metabolic redox chemistry with small molecule substrates including N2, H2O, H2, CO2, N2O, and CH4. Current interest in understanding how these metallocofactors function at the atomic level is enormous, especially in the context of sustainably feeding and fueling our planet; if we can understand how they work, there exists the possibility to design synthetic catalysts that function similarly with practical consequences in the realm of sustainability and human health. The aim of this conference is to include young and distinguished speakers and discussion leaders from different fields/skillsets related by the common theme of metallocofactors and biology. The health relevance of this meeting is strong, and mixing chemists, biochemists, structural biologists, molecular biologists, theorists, and medical researchers together in the context of the metallocofactor theme has the potential to catalyze much progress in the field.

Public health relevance
PUBLIC HEALTH RELEVANCE (provided by applicant): Metallocofactors are essential for virtually all forms of life, and much progress has been made on understanding their special chemical roles, their unique contributions to metabolism, and the promise they offer in the context of new science for human health and sustainability. The 2016 Gordon Research Conference on Metallocofactors will highlight the recent progress on the fundamental chemistry and mechanistic understanding of metallocofactors, as well as the latest developments in the area of eukaryotic metabolisms by metallocofactors and diseases related to abnormality of metallocofactor biogenesis. This is a unique opportunity to bring young and distinguished researchers of various disciplines and backgrounds together in a manner that will be conducive to creative thinking, which has the potential to catalyze significant progress in this field.